University of Minnesota Clinical Center for the Study of Acute Pancreatitis and Diabetes

Project Summary
Diabetes mellitus (DM) occurring after one or more episodes of acute pancreatitis (AP) is an important cause
of DM in adults, affecting about 15% of individuals by 2 years after an episode of AP. However, more rigorous
data are needed in larger and more diverse populations to define the exact incidence of new DM, risk factors
for developing DM, and pathophysiological mechanisms driving AP-related DM. To address this research gap,
the National Institute for Diabetes and Digestive and Kidney Diseases (NIDDK) formed the “Type 1 Diabetes
Acute Pancreatitis Consortium” (T1DAPC) in 2020, which subsequently launched the Diabetes Related to
Acute Pancreatitis and its Mechanisms (DREAM) study in 2022. The primary aims of the DREAM study are to
estimate the prevalence of and clinical risk factors for DM after AP, characterize islet function and endocrine
dysfunction after AP, and understand potential immunologic drivers of DM after AP. The University of
Minnesota has been a successful clinical site in the T1DAPC, as evidenced by: (1) strong recruitment
and exceptional retention (>95%) in DREAM; (2) leadership in the consortium including Co-Chairing the
consortium and DREAM protocol (contact P.I. Bellin); and (3) proposals and contributions for ancillary studies
and secondary data analyses. We will continue this important work in the next funding cycle of the T1DAPC.
Our site-specific Aims for this proposal are:
(1) To recruit and retain participants in the DREAM trial and to maintain academic engagement,
collaboration, and leadership within the T1DAPC. We will continue to achieve a high level of participant
engagement and retention in the DREAM study.
(2) To determine whether CT-derived abdominal and pancreatic fat measures predict future development of
DM and decline in beta cell function. We will use innovative machine learning approaches to estimate
pancreatic, visceral and subcutaneous fat in the DREAM participants on initial CT imaging and
determine its value in predicting later DM and beta cell function.
(3) To define the role of beta cell function and insulin resistance in DM development after AP. We will use
metabolic testing data collected in DREAM to determine metabolic pathways (reduced insulin secretion
and/or insulin resistance) driving DM development.
The results of DREAM will have a high impact in the clinical care of patients with AP, and are a first step
towards developing screening, treatment, and ultimately prevention strategies for AP-related DM.

Public health relevance
Project Narrative Diabetes mellitus (DM) occurs in as many as 15% of individuals at 2 years after an episode of acute pancreatitis (AP), but the mechanisms underlying DM after AP remain unknown. The “DREAM” study is a longitudinal cohort study designed to better define risk for and mechanisms of DM after one or more episodes of acute pancreatitis. During the next funding cycle, the University of Minnesota will continue to contribute to this collaborative effort through participant enrollment, participant follow up, and academic leadership.